Developmental Research Program

SUMMARY
The University of Hawai`i Cancer Center (UHCC) is the only National Cancer Institute-designated cancer
center in Hawai`i and the Pacific. The Center's mission is to reduce the burden of cancer through research,
community outreach, education and patient care with an emphasis on the unique ethnic, cultural and
environmental characteristics of Hawai`i and the Pacific. In alignment with this mission, the Developmental
Research Program (DRP) will draw upon areas of unique opportunity at UHCC to foster minority health
research that will improve our biological understanding of ethnic/racial differences in cancer risk and outcomes
in our catchment area and translate our findings into therapeutic, behavioral, and diagnostic clinical trials and
interventions that address these challenges. The DRP is a central element of the P50 for developing new
translational research projects in minority health that will nurture new lines of investigation, research
innovation, and collaboration. The funded pilot projects will provide important preliminary data for future large
research project applications and support their feasibility and impact. Also, DRP studies with translational
research potential may become full SPORE projects if the DRP study incorporates a human endpoint within
one of the project aims. Therefore, the DRP will be an engine for innovation in translational minority health
research at UHCC. As such we have integrated its activities closely with the leadership of the P50 and that of
the UHCC. Here we describe the process by which pilot projects will be solicited, reviewed, awarded, and
monitored. The goal of the DRP is to identify and fund 10 new research projects and collaborations over five
years that address minority health issues in UHCC's catchment area. In support of this goal, the DRP
coordinate pilot funding requests, reviews, and award activities and identify areas of unique opportunity and
potential collaborations. UHCC is poised to make seminal contributions to understanding and alleviating the
burden of cancer in our diverse catchment area through strategic minority health and disparities research. The
DRP will proactively take advantage of these advantages to foster creative work that will translate into
therapeutic, behavioral, and diagnostic clinical trials and interventions that directly impact minority health.
These projects will form the basis for the continued success of this minority health SPORE and expand its
impact by fostering the development of new research topics.